Human-specific splicing regulation in neurogenesis and disease

Project Summary
The cortex is responsible for many of our uniquely human cognitive abilities and distinguishes our closest
evolutionary relatives. Humans diverged from chimpanzees ~7mya and have accumulated several genomic
differences that could help explain human-specific aspects of cortical development. Many of the genomic
differences between humans and chimpanzees are in non-coding elements where they have been traditionally
studied as regulators of gene expression. In this proposal, I provide preliminary evidence that indicates additional
roles for these human-specific sequences in post-transcriptional gene expression. Over 40% of these human-
specific sequences are found within introns where I hypothesize, they contribute to the regulation of
splicing during human-specific neurodevelopment. In Aim 1, I will test the function of intronic human-specific
sequences to enhance and repress splice sites and ultimately alter species-specific isoform expression. Next as
a proof of concept, in Aim 2 I will investigate the consequences of changes in splicing and isoform production in
neurodevelopment. Specifically, I will be testing changes in splicing associated with an Autism-associated SNP
in the intron of Tenascin C (TNC). The SNP is located in a human-specific sequence and reverts the intronic
sequence back towards the chimpanzee sequence. The proposed research will define a novel mechanism of
action for human-specific non-coding regions of the genome in the regulation of post-transcriptional RNA
processing during cortical development and disease.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders, including autism spectrum disorder (ASD), impact many children in the United States. Many of these disorders are linked to mutations found in the non-coding genome where the impact of the mutation on gene expression regulation and neurogenesis remains largely unexplored. This project will advance our understanding of the function of non-coding human-specific elements in post-transcriptional gene expression during human brain development.